Locomotor function following transcutaneous electrical spinal cord stimulation in individuals with hemiplegic stroke

Project Abstract
Approximately 70% of the more than 7.2 million U.S. stroke survivors experience persistent gait deficits, including
reduced walking speed, asymmetrical walking patterns, and reduced lower limb coordination, which limit their
capacity for community ambulation. Current rehabilitation approaches are based on the assumption that stroke
impairs motor cortex function while the spinal cord is preserved and thus focus on stimulating the ipsilateral or
contralateral motor cortex during gait training to activate dormant or new pathways. Although animal models of
stroke reveal secondary degeneration of the cervical and lumbar spinal cord, suggesting that damage to the
spinal cord may effect functional recovery, little or no research has been done to elucidate spinal cord changes
in humans after stroke. Our objective is to evaluate the effects of spinal stimulation combined with gait training
after stroke and to investigate mechanisms underlying these effects. In preliminary work, we measured spinally
evoked motor potentials (sEMPs) generated by non-invasive, transcutaneous electrical spinal stimulation in 10
stroke survivors, 10 age-matched healthy controls, and 10 young healthy subjects. Stimulation thresholds were
significantly higher in stroke survivors than in controls and latency was significantly delayed in the paretic side
compared to the non-paretic side, indicating secondary effects of stroke on downstream spinal circuitry and
descending pathways. We also showed that spinal stimulation + symmetry-focused gait training (n=4) compared
to gait training alone (n=4), significantly improved step-length symmetry, walking speed (10-meter walk test,
10MWT), and walking endurance (6-minute walk test, 6MWT); these improvements exceeded the minimal
clinically important difference for chronic stroke. These results support our hypothesis that spinal stimulation may
increase gait training efficacy. In Aim 1, we will evaluate the short-term effects of spinal stimulation and sham
stimulation, with or without symmetry-focused gait training, on gait function (primary outcome: step-length
symmetry) and corticospinal circuitry in 25 stroke survivors. In Aim 2, we will conduct a randomized clinical trial
to evaluate the long-term effects of symmetry-focused gait training with stim or sham stimulation in stroke
survivors (n=25 per group). The primary outcome will be step-length symmetry; secondary outcomes include
temporal gait symmetry, speed (10MWT), muscle activation (electromyography), walking endurance (6MWT),
energy expenditure (Cosmed K4B2), upper and lower limb function (Fugl-Meyer Assessment), health status
(Stroke Impact Scale-16), and community activity (wearable sensors, Actigraph LLC). We will also investigate
mechanisms underlying the effects of spinal stimulation by examining sEMPs elicited in lower limb muscles by
cortical/subcortical stimulation of corticospinal axons and intracortical inhibition. This work will (i) identify short-
and long-term effects of spinal stimulation, (ii) validate spinal stimulation as a non-invasive method to restore
gait in chronic stroke, (iii) identify clinical measures that may determine response to spinal stimulation, and (iv)
identify underlying neuromodulatory mechanisms, which may provide additional treatment options.

Public health relevance
Project Narrative Restoration of community mobility is a goal for most of the 7.2 million stroke survivors in the US, who experience chronic gait impairments due to spasticity, contractures, and muscle weakness. Available therapies that focus on stimulation of affected ipsilateral and contralateral areas of the brain are not effective in the long term. Noninvasive electrical stimulation of the spinal cord, in combination with symmetry-focused gait training, may facilitate short-term or long-term modulation of spinal circuitry to improve walking function, and thus health and quality of life, in persons with chronic stroke.